AI-ADRD: Accelerating interventions of AD/ADRD via Machine learning methods

PROJECT SUMMARY
Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD) are neurodegenerative diseases
characterized by progressive loss of cognition and other neurobehavioral symptoms. In United States, there are
approximately 5.8 million patients live with AD/ADRD, and 97% of these patients are older than 65. In the last
decade, real-world data (RWD), including electronic health records (EHR) data and claims data, are becoming
increasingly valuable for drug repurposing of AD.
In this proposal, we plan to develop novel high dimensional semi-supervised learning and active learning
methods, as well as associated high dimensional hypothesis testing procedures, to accelerate interventions of
AD/ADRD, using drug repurposing of AD/ADRD as a motivating use case. We will address several key
challenges in real-world data including the high dimensionality of the risk factors, concomitant medication use,
and complex and heterogeneous progression trajectories of AD/ADRD. The success of this project will lead to
novel machine learning and statistical learning methods for facilitating drug repurposing for AD/ADRD based on
real-world data.

Public health relevance
PROJECT NARRATIVE We plan to develop novel high dimensional semi-supervised learning and active learning methods, as well as associated high dimensional hypothesis testing procedures, to accelerate interventions of Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD), using electronic health record (EHR)-based drug repurposing as a motivating use case.